Role of fatty acid metabolism in optic nerve hypoplasia

ABSTRACT
Optic nerve hypoplasia (ONH) is a very common congenital optic nerve (ON) disorder and is the leading cause
of childhood blindness in developed nations. ONH incidence has increased ~8-fold over the last two decades.
ONH is characterized by a thin, underdeveloped ON that often results from secondary loss of retinal ganglion
cells (RGCs). The most common prenatal determinants of ONH are a young primiparous mother, an unhealthy
maternal lifestyle including alcohol abuse, and nutritional deprivation. We have developed and published murine
models of ONH by manipulating the X-linked gene CASK, since CASK mutations in humans are associated with
ONH. The ONH pathology of CASK mutant mice recapitulates human ONH, including the timing of pathology
onset (after RGC development; i.e., secondary loss) and the non-progressive nature of the pathology.
Biochemical experiments show that CASK interacts with metabolic proteins and modulates mitochondrial
function. CASK deficiency leads to increased fatty acid oxidation and a deficit of the ω-6 fatty acid arachidonic
acid (ARA) in the central nervous system (CNS). ARA deficiency is also observed in other conditions associated
with ONH. We hypothesize that ONH results from an early ARA deficit, thus ONH can be exacerbated by
perturbing brain ARA metabolism (via astrocyte dysfunction) and ameliorated by dietary ARA
supplementation. During the third trimester, ARA is exclusively obtained from the mother; in neonates, brain
ARA is also obtained from the diet until adequate enzymatic activity (conversion of the essential fatty acid linoleic
acid into ARA) is reached. This post-neonatal shift in ARA acquisition from diet to synthesis may contribute to
ONH’s non-progressive nature. In the CNS, fatty acid metabolism (including ARA uptake and production) occurs
predominantly in astrocytes. In this proposal we plan to test our hypothesis in two independent ONH mouse
models: 1) CASK(+/-) heterozygous knockout mice, and 2) a previously published fetal alcohol syndrome (FAS)
mouse model. With these models, we will examine mitochondrial metabolism, oxidative damage and fatty acid
metabolic defects in the retina, ON and brain. We will also quantify levels of two ω-fatty acids (docosahexaenoic
acid and ARA), as well as phospholipids in the ON of both types of ONH mice. Next, we will genetically disrupt
the function of astrocytes (crucial for brain ARA metabolism) in a CASK hypomorph ONH model by complete
deletion of CASK in astrocytes. We will investigate if this manipulation exacerbates the metabolic defect and
ONH as assessed both morphologically and functionally, using a visual behavioral assay and an innovative
electrophysiological tool called Network Response to Visual Excitation (NeRVE). Finally, we will test if ARA
supplementation ameliorates ONH in the two models described above. Our study is likely to identify ARA
deficiency as the final common pathway that explains ONH’s association with nutritional deprivation, maternal
diabetes, infantile cholestasis and FAS. Positive results from ARA supplementation will be readily translatable.

Public health relevance
PROJECT NARRATIVE Optic nerve hypoplasia (ONH) is one of the most common congenital disorders of the optic disc and an increasingly prevalent cause of childhood blindness. Not much is known about this pervasive disease with very few animal models available. In our current proposal we describe a translational project on this disorder, one which is also likely to delineate a common pathway linking association of ONH with nutritional deprivation, infantile cholestasis, maternal diabetes, fetal alcohol syndrome, mitochondrial cytopathies, and peroxisomal disorders.